Genetic Vulnerability for Sustained Multi-Substance Use in MVP

Detecting Genetic Susceptibility for Fatty Liver Disease in Lean vs. Non-lean Individuals: Use of a Deep
Learning Algorithm
PROJECT SUMMARY/ABSTRACT
Fatty liver disease (FLD) is the most common liver disease in the world, affecting nearly 1 billion people.
Although it commonly occurs among overweight and obese (non-lean) individuals, a quarter of those affected
are lean. Paradoxically, although lean individuals with FLD are less likely to have cardiometabolic risk factors
(e.g., diabetes, hypertension, and dyslipidemia), they have a two-fold increased risk of cardiovascular and
liver-related mortality. Metabolic dysfunction and alcohol use are the most common causes of FLD. However,
they have overlapping genetic risk factors and cannot be distinguished by medical imaging or histopathology.
To date, it remains unknown if there are any lean-specific genetic variants for FLD. Current thresholds of
alcohol consumption associated with FLD are arbitrary, and it is also unclear if alcohol consumption accounts
for the difference in outcomes observed between lean and non-lean individuals with FLD. With the unique
clinical and imaging data available within the Veterans’ Affairs (VA) system, combined with large-scale genetic
data available in the Million Veteran Program (MVP), the goal of this project is to identify convergent and
divergent features of lean and non-lean FLD by comparing associated clinical and genetic risk factors in those
with and without substantial alcohol exposure. We have established a cohort of over 81,000 veterans in the
MVP with genetic data who underwent non-contrast abdominal computed tomography (CT) imaging for any
indication in the context of clinical care between 2011 to 2023. Our preliminary study of 45 lean and 72 non-
lean individuals shows that Automatic Liver Attenuation Region-of-interest-based Measurement (ALARM), a
deep learning tool was accurate in identifying hepatic steatosis in both lean and non-lean individuals compared
to blinded expert radiology read. The central hypothesis to be tested is that application of the ALARM tool to
non-contrast abdominal CT scans will accurately classify lean FLD and improve the identification of new
genetic variants for non-alcoholic and alcohol-related FLD in lean individuals. This hypothesis will be tested
through three specific aims: (1) We will assess the accuracy of ALARM in phenotyping lean FLD; (2) We will
characterize lean and non-lean FLD by level of alcohol consumption in the MVP cohort; and (3) Identify genetic
variants associated with lean FLD.
The proposed project will assemble the largest ever multi-ancestry cohort of persons with FLD based on the
application of artificial intelligence methods to clinically obtained non-contrast abdominal CT scans. The
proposed research will improve our understanding of the clinical and genetic underpinnings of FLD in lean
individuals and how alcohol consumption impacts these clinical and genetic risk factors. We expect to identify
distinct and potentially novel lean-specific genetic variants associated with FLD. The findings from this
proposed study will lay the foundation for developing efficient and cost-effective screening guidelines to move
precision medicine into clinical practice and possibly change screening guidelines for lean FLD in the general
VA population. The candidate has clinical expertise in hepatology and will take advantage of the resources
provided by his expert mentorship team to become an independent VA-funded physician-scientist specializing
in the genetics of fatty liver disease.

Public health relevance
PROJECT NARRATIVE Remarkably, 25% of patients with fatty liver disease (FLD) are lean and compared to non-lean (overweight and obese) individuals with FLD, they have a two-fold increased risk of cardiovascular and liver-related mortality. Our goal is to understand convergent and divergent features of lean and non-lean FLD, by comparing associated clinical and genetic risk factors in those with and without substantial alcohol exposure in the VA Million Veteran Program (MVP). This project will assemble the largest ever multi-ancestry cohort of persons with and without FLD based on the application of Automatic Liver Attenuation Region-of-interest-based Measurement (ALARM), a deep learning tool to clinically obtained non-contrast abdominal CT scans. This work has the potential to substantially improve our understanding of the clinical and genetic drivers of FLD in a quarter of those affected. Given the large number of such patients within the VA health system and their increased mortality, this work has the potential to significantly impact the practice of clinical medicine.